Competing basolateral amygdala inputs to the infralimbic and prelimbic cortices in cocaine-seeking behavior

Project Summary
Relapse to cocaine use, and the underlying failure to inhibit cocaine-seeking behavior, remain significant barriers
to the treatment of cocaine use disorder. However, our understanding of the neural pathways and network
mechanisms underlying the inhibition of cocaine seeking remain insufficient. Previous studies investigating fear
conditioning and drug seeking suggest that, often, the infralimbic cortex (IL) inhibits and the prelimbic cortex (PL)
promotes such behaviors. Although downstream projections from these brain regions have been identified in the
involvement of regulating fear conditioning and drug seeking, it is unknown what inputs to these regions
determine their influence over cocaine-seeking behavior. Evidence from fear conditioning studies suggests that
separate subpopulations of basolateral amygdala (BLA) neurons project to the PL vs. IL and oppose each other
for control over fear conditioning vs. the extinction thereof. These findings raise the possibility that the BLA is a
key region influencing PL and IL activity and determining the degree of cocaine-seeking behavior. Indeed, global
manipulations suggest that the BLA promotes cocaine seeking as well as fear conditioning, but more recent
reports suggest the BLA may also have a role in extinction and inhibition of drug seeking. However, whether the
BLA separately regulates the IL and PL to extinguish or engage in cocaine seeking and how these regions
engage in complex network interactions during cocaine seeking has never been investigated. Therefore, the
goal of this proposal is to examine BLA→IL and BLA→PL pathways in cocaine extinction learning using
optogenetics (Aim 1) and examine network activity in the BLA, IL, and PL simultaneously during cocaine
seeking via multi-site electrophysiological recordings (Aim 2). The overall hypothesis is that the BLA-IL
system is critical for the extinction of cocaine seeking, whereas the BLA-PL system opposes this effect and that
neural activity between these systems during cocaine seeking will reflect the degree of cocaine-seeking
behaviors. The findings from these experiments will provide fundamental knowledge regarding the neural
systems that regulate cocaine-seeking behaviors. The sponsor (Dr. Ryan LaLumiere) and co-sponsor (Dr.
Rainbo Hultman) for this proposal are leaders in the field of drug-seeking behavior and mood disorder,
respectively, and have expertise in all techniques needed for the proposed research. Moreover, the University
of Iowa and the Psychological and Brain Sciences Graduate Program provide an excellent environment and
resources for neuroscience research. The training plan for this work includes training in the technical and
conceptual skills for the proposed research along with development of teaching and mentoring skills, networking
through neuroscience conferences, scientific writing and presentations. Therefore, the applicant will receive first-
rate training that will propel her forward in her career and help to achieve her goals of becoming an independent
investigator.

Public health relevance
Project Narrative Relapse to cocaine use remains a pervasive and difficult-to-treat problem for addressing cocaine use disorder. In particular, the specific neural pathways and network activity underlying the extinction and inhibition of cocaine seeking remain unclear. By elucidating the circuits and network function underlying relapse-like behaviors, this proposal will provide fundamental knowledge regarding cocaine use disorder and lay the groundwork for future studies that can use such knowledge to develop better treatments to prevent relapse.